Contribution of the Skull Bone Marrow during Neuroinflammation

ABSTRACT
Perturbations in redox signaling are associated with multiple neurological disorders, ranging from
neurodegenerative diseases to brain tumors. The brain tumor glioblastoma (GBM) is a devastating disease and
improved understanding of its altered bioenergetics and redox status is likely to improve treatment options. GBM
is highly heterogeneous and includes cells that have altered redox states and similarities to neural stem cells,
called brain tumor initiating cells (BTICs), that cause tumor recurrence. A redox regulator we identified as being
elevated in BTICs is GTP cyclohydrolase I (GCH1), a gene known to be altered in dopa-responsive dystonia and
Parkinson’s disease. Importantly, GCH1, a rate-limiting enzyme that produces tetrahydrobiopterin (BH4),
maintains BTIC survival via suppressing damage caused by reactive oxygen species (ROS). Mitigating ROS via
GCH1 is one mechanism by which BTICs may survive hostile tumor microenvironments, like nutrient deprivation.
As redox biology and metabolism are closely linked, I hypothesize that the metabolic consequence of high GCH1
confers protection to oxidatively vulnerable lipids to support BTIC growth. My current findings during the F99
phase strongly suggest that the GCH1/BH4 pathway increases lipid utilization and plays a vital role in protecting
oxidatively vulnerable lipids during metabolic reprogramming. The successful investigation of oxidative stress
responses via GCH1 and its relationship with metabolism will reveal metabolic vulnerabilities for clinical
intervention. In addition, my studies are likely to be informative for other neurodegenerative diseases where
GCH1 is altered, or ROS is unregulated.
For the K99 phase, continued studies in brain tumor models will shift focus toward elucidating the impact of GBM
on the bone marrow (BM) microenvironment in regulating immune suppression and myeloid recruitment.
Infiltrating BM cells are a significant contributor to the tumor microenvironment where GBM co-opts these cells
to drive disease progression. Brain tumors are excitatory cells that readily release/uptake neurotransmitters for
their growth, but this high neural activity has not been investigated in the BM, despite the BM being innervated.
BM cells have several neuroreceptors, suggesting these cells can readily respond to neural cues. As BM
innervation is important for its maintenance and immune mobilization, aberrant neural activity from GBM that
remodel the BM is unexplored. Therefore, using BM denervation studies in GBM models, I will assess neural
activity as a critical player in myeloid skewing in the BM and recruit immunosuppressive myeloid cells to the
brain. Elucidating the crosstalk between glioma-to-bone marrow through neural communication provides an
opportunity to disrupt signaling pharmacologically without having to consider drugs for blood brain barrier
penetrance.

Public health relevance
PROJECT NARRATIVE Brain pathologies such as neurodegenerative diseases and brain tumors have alterations in redox signaling. In the F99 phase of this proposal, brain tumor models are utilized to elucidate the mechanism by which brain tumor initiating cells suppress oxidative damage to promote their survival. For the K00 phase, continued studies with brain tumor models will shift focus to elucidate impacts on the bone marrow (BM) microenvironment to alter myeloid lineages and recruitment into the brain.